A Latin American biobank for large-scale genetics research on severe mental illness

PROJECT SUMMARY / ABSTRACT This supplement to NIMH grant R01 MH123157 (Latin American Biobank of Severe Mental Illness [LAB-SMI]) will enable the UCLA investigators of this project to establish a DNA repository for this project. The parent project aims to reverse the underrepresentation of populations from Latin America in psychiatric genetic research. It will do so by recruiting and phenotyping 92,000 new participants from Colombia (42,000 individuals diagnosed with SMI and 50,000 population controls) and obtaining blood samples from these participants that will provide the DNA for genome wide genetic studies. The supplement will fund the investigators to augment the processes proposed in the parent grant for DNA extraction and storage so as to: (1) obtain larger amounts of high-quality DNA; (2) store and track the DNA samples in a way that will facilitate the use of the samples beyond the specific aims of the parent grant; (3) make aliquots of DNA available to qualified investigators based on protocols established with NIMH program staff. The supplement will add to the value of the parent project as a unique resource for the first well-powered genetic studies of psychiatric disorders in populations of Latin American ancestry and for exploring the genetic architecture of SMI phenotypes.

Public health relevance
PROJECT NARRATIVE To reverse the underrepresentation of Latin American populations in psychiatric genetic research, we initiated the Latin American Biobank for Severe Mental Illness (LAB-SMI) project, which is recruiting 42,000 SMI cases and 50,000 population controls in Colombia. This supplement to LAB- SMI will enable UCLA to act as a DNA repository, extracting and storing high quality DNA and making aliquots available to qualified investigators.